Pan-Organ Spatial Atlas of Immunosenescence: Decoding Immune Aging Across Tissues and Scales

NIH SenNet Administrative Supplement Grant Application
Pan-Organ Spatial Atlas of Immunosenescence: Decoding Immune Aging Across Tissues and Scales
(PIs: Rong Fan, Katy Börner)
SUMMARY
Immunosenescence, the progressive decline in immune function due to cellular aging, is a critical contributor to
increased vulnerability to infections, chronic inflammation, and immune dysfunction in aging populations. This
process is highly heterogeneous, varying across immune organs and tissue environments, but current
understanding at the organ- and cell-type-specific level remains limited due to the rarity and diversity of
senescent immune cells in situ. We hypothesize that immunosenescent states both reflect and actively remodel
local tissue niches, characterized by distinct molecular features including cell cycle arrest markers, metabolic
stress signatures, DNA damage indicators, and senescence-associated secretory phenotypes (SASP). To
address this, we propose an integrated, multi-modal spatial profiling approach leveraging cutting-edge
technologies to comprehensively map senescent immune cells across multiple organs, ages, and physiological
conditions in mouse models. Utilizing a high-plex CODEX immunofluorescence panel targeting key senescence
and immune markers, we will spatially resolve diverse senescent cell phenotypes (senotypes) across lymphoid
and non-lymphoid tissues. This will be complemented by DBiT spatial transcriptomic and epigenomic sequencing
to link these senotypic states to their underlying genome-wide molecular mechanisms directly in the tissue
context. Building on Dr. Rong Fan’s expertise in spatial multi-omics and Dr. Katy Börner’s computational
platforms for data integration and visualization, we will create a comprehensive pan-organ immunosenescence
atlas. In addition, we will develop an interactive, multi-scale web platform based on the Cell Distance Explorer
framework to enable researchers to explore and compare senescence patterns across organs, ages, sexes, and
experimental perturbations. This platform will provide intuitive visualization tools ranging from whole-body organ
maps to detailed tissue- and single-cell-level spatial analyses. Validation efforts will ensure the tool’s accuracy
and usability through benchmarking with established senescence biomarkers and histological assessments,
ultimately making the platform publicly available through the Human Reference Atlas portal (humanatlas.io). By
filling a critical knowledge gap in spatial immunosenescence, this project will provide unprecedented insights into
the spatial dynamics and systemic effects of immune aging. It promises to transform biomedical research by
enabling detailed exploration of senescent immune cell biology at multiple scales, thereby accelerating
discoveries in healthy aging, immune function, and therapeutic development.

Public health relevance
Project Narrative This project aims to map all major cell types and diverse senescent states (senotypes) at scale across multiple mouse organs using high-plex immunofluorescence imaging, followed by spatial transcriptomic or epigenomic profiling to link senotypic states to their underlying molecular mechanisms, and then build a comprehensive, pan-organ immunosenescence atlas as well as data visualization pipelines to investigate how immuno-senescence develops and evolves across the body with age and perturbations.